DIETARY SODIUM, RACE, AND CARDIOVASCULAR RESPONSES TO STRESS

The purpose of this study is to examine the effects of differing levels of dietary sodium on cardiovascular responses to stress in young black and white subjects classified as normotensive or as borderline hypertensive (aged 18-30). This will determine whether subjects at risk for hypertension exhibit augmented vascular reactivity to a vasoconstrictive stimulus during sodium loading.